TREATMENT OF HEMANGIOMAS WITH ALFA INTERFERON

This study aim was to look at the efficacy of alfa interferon in the treatment of hemangiomas that are either destructive of tissue, disabling to the patient, or life-threatening. This includes determinig the side-effects and/or complications, if any, of alfa interferon therapy given over a period of time. The investigators will also determine whether urinary and/or serum levels of basic fibroblast growth factor (bFGF) can be used: 1) as a marker of disease activity; 2) as a marker of treatment efficacy; and 3) as a biochemical marker to distinguish between hemangiomas and other vascular anomalies.